Maximizing Use of High-Quality Evidence in Eye Care: Cochrane Eyes and Vision US Project

PROJECT ABSTRACT
Vision healthcare should be based on science. Cochrane is the only international organization that has as its core mission to synthesize (via systematic reviews) and keep up to date the world’s literature for all of healthcare. Systematic reviews use a highly structured and reproducible methodology to identify, appraise, and synthesize available evidence for specific clinical questions. Cochrane Eyes and Vision (CEV) aims to prepare and promote access to systematic reviews of interventions used to prevent, diagnose, or treat eye conditions and visual impairment.

Since 2002, the CEV US Project (CEV@US) has published 101 systematic review protocols, 104 systematic reviews, and 75 methodological papers and book chapters; has educated over 100,000 individuals in methods for systematic reviews; and has informed 121 clinical practice guidelines in the US and internationally. Since its start, CEV@US has been laying the groundwork for having an impact on practicing clinicians: demonstrating to all who are interested how to conduct an excellent systematic review (e.g., education, journals, methods research), how to apply this knowledge (e.g., clinical practice guidelines and decision-support applications), and forming important partnerships (e.g., with clinicians and patients/consumers).

The focus of our 2022-2027 competitive renewal is impact – impact of CEV reviews on clinical practice.

Aim 1: We will prepare systematic reviews that address prioritized questions in collaboration with clinicians and methodologists, publish the reviews, and regularly update them as new research emerges. We will apply state-of-art methods in producing these reviews. Aim 2: We will partner with individual (e.g., clinicians, patients) and organizational stakeholders (e.g., professional societies, academic medical centers, journals) to ensure that the knowledge underpinning clinical practice is reliable, available, and applied. Aim 3: We will build research capacity by educating health professionals. Our education is flexible and tailored, and is offered online and in-person, via professional organizations, clinical programs, and one-time workshops. Aim 4: We will conduct foundational methodological research related to systematic reviews and influence the field of evidence synthesis. We will evaluate the impact CEV@US activities using a mixed-method study. Aim 5: We will promote evidence-informed decision making by disseminating the results of our research widely.

Public health relevance
PROJECT NARRATIVE To date, the Cochrane Eyes and Vision US Project (CEV@US) has spearheaded production of systematic reviews aimed at preventing, diagnosing, or treating eye conditions; these reviews inform decisions about vision care and lead to preservation of sight. We will partner with individual and organizational stakeholders to prepare and update systematic reviews on high-priority topics, influence evidence-based guidelines and knowledge translation activities, build research capacity through training, conduct fundamental methodological research, and disseminate our findings to impact practice.